Characterizing the virologic and immunologic signatures of HIV exceptional control

PROJECT SUMMARY/ABSTRACT
Typical elite control of HIV infection is no longer considered an optimal model for antiretroviral therapy (ART)-
free remission due to increased transcriptional activity, chronic inflammation, and immune dysfunction in these
individuals. “Exceptional control” is a related but distinct phenotype of natural HIV control that is now of great
interest to the HIV cure community. The overarching objective of this proposal is to identify and characterize
individuals exhibiting exceptional control in blood and tissues, and to initiate studies that seek to understand the
mechanism by which this is achieved. We have several inter-related hypotheses: (1) exceptional controllers
exhibit greater control over HIV replication in lymphoid tissues than typical elite controllers, despite comparable
levels of control in peripheral blood, (2) exceptional controllers will have less systemic inflammation than typical
elite controllers and ART-treated individuals and these levels will be similar to those in uninfected individuals, (3)
in contrast to typical elite controllers, exceptional controllers who have initiated ART and then interrupt therapy
in a highly monitored setting will exhibit no change in markers of residual viremia, inflammation, or immune
activation. To investigate these hypotheses, we will begin by identifying natural HIV controllers in the UCSF
SCOPE cohort who in the absence of ART have very low levels of intact proviral HIV DNA in a large number of
peripheral blood CD4+ T cells; these will be the putative exceptional controllers. Individuals who have higher
levels of intact proviral DNA will be considered typical elite controllers. In Aim 1, we will perform a cross-sectional
study using gut biopsies and lymph node tissue aspirates to measure the size and distribution of the HIV reservoir
at steady-state, comparing exceptional controllers with typical elite controllers. In Aim 2, we will perform a cross-
sectional study of the immunologic consequences of exceptional control by measuring immune activation with
PET-MR imaging and soluble and cell-associated markers of inflammation and immune system activation. We
will compare exceptional controllers at steady-state with typical elite controllers, non-controllers on ART, and
uninfected individuals. In Aim 3, we will analyze samples collected in an externally funded prospective study of
HIV controllers and non-controllers interrupting ART to determine the virologic and immunologic changes that
occur at the earliest timepoints when the host first encounters rebounding virus (the “intercept”). We anticipate
that exceptional controllers interrupting therapy will demonstrate no substantial increase in these markers in
contrast with the other groups. If our hypotheses are correct, we expect that exceptional controllers will
demonstrate significant differences compared with typical elite controllers and non-controllers, will be
indistinguishable from people without HIV infection, and will not have benefitted from ART. If this is the case, it
will lead to further mechanistic studies to understand the process by which this level of control is achieved and
might inform further work to develop a model for HIV “remission.”

Public health relevance
PROJECT NARRATIVE This study investigates the mechanism by which a unique group (“exceptional controllers”) are able to control HIV infection without HIV medications. We hypothesize that exceptional controllers have very low levels of virus in the lymphoid tissues, have levels of inflammation similar to people without HIV, and do not benefit from HIV medications. If these hypotheses are true, exceptional controllers might serve as a model for a treatment-free HIV “remission.”